Systems Antibody Immunology of the Malaria Sporozoite Vaccine

Project Summary
Over 200 million people are infected with malaria every year. An effective and long-lasting vaccine will
be essential for the elimination and eradication of malaria in Sub-Sharan Africa and worldwide. Though WHO-
approved circumsporozoite protein (CSP) protein vaccine RTS,S is the only vaccine in current use, it provides
<50% protection that is also short lived. The proposed research will delve into the humoral immunity of the
whole sporozoite vaccine (PfSPZ), a model system to identify protective immune responses beyond the
immunodominant epitope CSP - essential insights needed to create new, highly effective malaria vaccines.
This proposal describes a five-year career development plan to study humoral immunity to the malaria-
causing pathogen Plasmodium falciparum. Though antibodies are important for PfSPZ-mediated protection,
the protective antibody targets and functions remains unknown. Further, PfSPZ's efficacy drops in malaria-
exposed individuals and how pre-existing anti-malarial antibodies affect PfSPZ vaccination remains
unanswered. Our preliminary systems serology analysis of malaria naïve PfSPZ vaccinees has suggested a
new protective role for IgM antibodies to SSP2/TRAP, a malaria host cell recognition and invasion protein, and
validated our approach. The studies proposed here are to 1) define the functional antibody correlates of
protection in malaria-exposed individuals and the effect of pre-existing immunity 2) identify new correlates of
protection with a whole-proteome approach, and 3) define mechanisms of anti-sporozoite immunity of
SSP2/TRAP IgM antibodies. These aims will be carried out with human serum from PfSPZ vaccination and
controlled human malaria infection (CHMI) challenge trials in malaria-naïve and exposed individuals.
The candidate is currently an Associate Physician at Brigham and Women's Hospital, Instructor in
Medicine at Harvard Medical School (HMS), and Research Fellow at the Ragon Institute with an ongoing
commitment of 80% time to research. The proposal is supported by an expert mentor in humoral immunology,
HMS Professor Facundo Batista, and co-Mentored by expert in systems biology MIT Professor Douglas
Lauffenburger. The candidate is supported by a SAC containing an expert in phage display serological assays,
HMS Professor Stephen Elledge, an expert in malaria vaccinology, NIAID Chief of Cellular Immunology Dr. Robert
Seder, and expert in malaria host-pathogen interactions and pre-erythrocytic immunity University of Washington
Associate Professor Noah Sather. Building on the candidate's doctoral training in malaria pathogenesis and
genomics, this proposal will further his training in humoral immunology, systems biology, and bioinformatics as well
as research scientist-focused professional development and responsible conduct of research coursework.
Completion of this comprehensive training plan will enable the candidate to create a successful and unique research
program, obtain independent funding, and transition to running an independent laboratory focused on malaria
antibody immunology, phage display serologic assay tool development, and vaccinology.

Public health relevance
Project Narrative An effective and long-lasting vaccine will be essential to eliminate and eradicate malaria, a disease that afflicts more than 200 million people every year. The proposed research delves into humoral immunity to the PfSPZ vaccine, the only malaria vaccine with >90% protective efficacy, and how protective immune responses may differ in people who have already been infected with malaria. These insights will help us design the next generation of malaria vaccines that will be highly effective in the United States and Sub-Saharan Africa.